Epidemiology of Alcohol Problems: Alcohol-Related Disparities

ABSTRACT: Overall
The continuation of the Alcohol Research Group's (ARG) National Alcohol Research Center, Epidemiology of
Alcohol Problems: Alcohol-related Disparities, brings increased focus to the NIH's priority area of disparities
in health, mental health and social problems. The Center, building on its groundbreaking conceptual and
methodological contributions for over 40 years, studies the complex interactions between drinking patterns
across the life-course, demographic characteristics, sociocultural and drinking contexts, community and policy
factors, and problem outcomes, both in the general population and with attention to high-risk subgroups.
Recognizing the importance of disparities in alcohol use patterns, problems and health outcomes, and the
significant gaps in the knowledge base in this area despite our past contributions, we continue to focus on
disparities in the 2021-25 Center, organized around four research projects: the National Alcohol Surveys
(NAS) Project 1 that would allow continued implementation of our NAS, which is a repeated, cross-sectional,
national epidemiological survey with large oversamples of Blacks and Latinos and individually-linked geo-
referenced area measures, conducted with comparable measurement every 5 years and facilitating disparities
analyses focused on race/ethnicity and socioeconomic groups; the Health Disparities Project 2 addressing
racial/ethnic and socioeconomic disparities in alcohol-related injuries, diabetes and heart-related outcomes; the
Alcohol Services Project 3 on the quality of and disparities in alcohol-related care received and how this may
be changing with health reform; and the High-Intensity Drinking (HID) Project 4 involving trends in HID,
analyses of the characteristics of events where 8+/12+ drinks are consumed, characterization and classification
of the individuals that drink at these levels and the problems they experience. Supporting these projects are the
Administrative Core, facilitating Center integration, synergy and success, training, dissemination and
collaborations, and one scientific Core: the Statistical and Data Services (SDS) Core, which brings together
analytic expertise, experienced data management skills and training for ARG scientists and research staff. These
Cores and Projects illustrate a rich diversity of approaches and compelling public health questions, and stand to
inform future research in the disparities arena with conceptual, measurement and analytical innovations.

Public health relevance
PUBLIC HEALTH RELEVANCE The proposed Center provides resources, training, data and statistical expertise for the study of alcohol-related health, mental health and social problem disparities in the US arising from differences between racial/ethnic and socioeconomic group and sexual identity and rurality. Research projects will provide insights in to the drinking of those with alcohol-related health conditions, racial/ethnic and socioeconomic disparities in alcohol-related problems, the role of inflammation in associations between alcohol use and mental health issues, disparities in access and utilization of screening for alcohol problems, use of pharmacotherapy and treatment completion, co- use of alcohol and other drugs, and events involving high-intensity drinking and drinkers who participate in them. Knowledge gained will further understanding of alcohol-related disparities and will strengthen the design, implementation and targeting of interventions to address these.